Enhancing Engagement with Digital Mental Health Care

Enhancing Engagement with Digital Mental Health Care
Abstract
Digital mental health (DMH) is the use of technology to improve population well-being through rapid disease
detection, outcome measurement, and care 1. Although several randomized clinical trials have demonstrated that
digital mental health tools are highly effective 2-6, most consumers do not sustain their use of these tools 7-9. The
field currently lacks an understanding of DMH tool engagement, how engagement is associated with well-being,
and what practices are effective at sustaining engagement. In this partnership between Mental Health America
(MHA), Talkspace (TS) and the University of Washington (UW), we propose a naturalistic and experimental,
theory-driven program 10,11 of research, with the aim of understanding 1) how consumer engagement in self-help
and clinician assisted DMH varies and what engagement patterns exist, 2) the association between patterns of
engagement and important consumer outcomes, and 3) the effectiveness of personalized strategies for optimal
engagement with DMH treatment. This study will prospectively follow a large, naturalistic sample of MHA and
TS consumers, and will apply machine learning, user-centered design strategies, and micro-randomized and
sequential multiple assignment randomized (SMART) trials to address these aims. As is usual practice for both
platforms, consumers will complete online mental health screening and assessment, and we will be able to
classify participants by disease status and symptom severity. The sample we will be working with will not be
limited by diagnosis or co-morbidities. Participants will be 10 years old and older and enter the MHA and TS
platforms prospectively over 4 years. In order to test the first aim, we will identify a minimum of 100,000
consumers who have accessed MHA and TS platforms in the past. Participant data will be analyzed statistically
to reveal differences in engagement and dropout across groups based on demographics, symptoms and platform
activity. For aim 2, we will use supervised machine learning techniques to identify subtypes based on consumer
demographics, engagement patterns with DMH, reasons for disengagement, success of existing MHA and TS
engagement strategies, and satisfaction with the DMH tools, that are predictive of future engagement patterns.
Finally, based on the outcomes from aim 2, in aim 3 we will conduct focus groups applying user-centered design
strategies to identify and co-build potentially effective engagement strategies for particular client subtypes. We
will then conduct a series of micro-randomized and SMART trials to determine which theory-driven engagement
strategies, co-designed with users, have the greatest fit with subtypes developed under aim 2. We will test the
effectiveness of these strategies to 1) prevent disengagement from those who are more likely to have poor
outcomes after disengagement, 2) improve movement from motivation to volition and, 3) enhance optimal dose
of DMH engagement and consequently improve mental health outcomes. These data will be analyzed using
longitudinal mixed effects models with effect coding to estimate the effectiveness of each strategy on client
engagement behavior and mental health outcomes.

Public health relevance
Project Narrative: This proposal is a partnership between Mental Health America (MHA), a nonprofit mental health advocacy and resource organization, Talkspace (TS), a for-profit, online digital psychotherapy organization, and the University of Washington’s Schools of Medicine and Computer Science Engineering (UW). The purpose of this partnership is to create a digital mental health research platform leveraging MHA and TS’s marketing platforms and consumer base to describe the characteristics of optimal engagement with digital mental health treatment, and to identify effective, personalized methods to enhance motivation to engage in digital mental health treatment in order to improve mental health outcomes. These aims will be met by identifying and following at least 100,000 MHA and TS consumers over the next 4 years, apply machine learning approaches to characterizing client engagement subtypes, and apply micro-randomized trials to study the effectiveness of motivational enhancement strategies and response to digital mental health treatment.